HCMV infection downregulates nidogen 1 and myelin protein zero

ABSTRACT from AI139503 Human Cytomegalovirus (HCMV) is a leading cause of congenital birth
defects. The most common sequela observed in symptomatic infants is sensorineural hearing loss
(SNHL). SNHL is also observed, somewhat perplexingly, during early childhood, developing over a
period of years in children born hearing competent and asymptomatic for infection at birth. The most
abundant peripheral nervous system (PNS) myelin protein, myelin protein zero (MPZ), is largely
responsible for compaction of the PNS myelin sheath. Charcot-Marie-Tooth Type 1B and Dejerine-Sottas
syndromes patients, with mutations in MPZ, frequently suffer from late-onset SNHL, similar to that
observed in HCMV congenitally-infected children. MPZ expression is dramatically decreased in
congenital HCMV-infected tissue samples. Schwann cells (SCs) are the only cells in the body that
produce MPZ. HCMV infection of SCs, or sole expression of the HCMV tegument protein pp71 in culture,
causes large decreases in MPZ mRNA levels. SCs express MPZ protein only when directly contacting
the neurons they sheathe, making a tractable co-culture system essential to studying defects in
myelination. Substantial literature describes rat SC/neuron co-culture; however, very little work has
reported using only human cells, essential for the study of species-restricted Human CMV pathogenesis.
We have developed an all-human three-dimensional (3D) SC/neuron co-culture system, amenable to the
study of HCMV interactions. Our preliminary experiments have produced robust neurite outgrowth,
SC/neuron interactions, MPZ expression and myelination. Initial experiments with pp71-expressing SCs
produced very different interactions between the cell types and no evidence of myelination. In this
application, we propose three AIMS. AIM 1 will fully characterize the co-culture system, establishing the
baseline parameters of outgrowth and myelination, additionally assessing the functionality of the system
using nerve conduction velocity studies, over a 30-day timecourse using wildtype SCs. After defining the
co-culture system’s baseline parameters, AIM 2 will assess the ramifications of HCMV infection and
pp71 expression on all parameters defined in AIM 1. AIM 3 will utilize the co-culture system to examine
crosstalk between the extracellular matrix (ECM) and myelin production, MPZ in particular, since the
literature suggests a critical link between the ECM and SCs’ ability to properly myelinate neurons. We
believe this 3D system will enable us to accurately assess the effects of HCMV infection on the
developing PNS. Moreover, we believe our new system has the potential to be utilized by the wider
scientific community studying interactions between glia and neurons and associated defects in
myelination with an eye on its utilization as an efficient platform for drug discovery and development.

Public health relevance
Project Narrative from AI139503 Human Cytomegalovirus is a leading cause of birth defects. Those defects can dramatically impact the lives of the children (and their parents) that suffer from them. My research is aimed at understanding the underlying mechanisms involved in the development of those defects to ameliorate and, hopefully, prevent their occurrence.